Alphavirus Pathogenesis and Immunity

PROJECT SUMMARY
Chikungunya (CHIKV) and Ross River (RRV) viruses are mosquito-transmitted RNA viruses that cause explosive
epidemics of debilitating acute and chronic polyarthralgia/polyarthritis. Although CD8+ T cells recognize and
eliminate virus-infected cells, their role in arthritogenic alphavirus infection has remained enigmatic. Remarkably,
in mouse models of CHIKV and RRV infection, viral burden in joint tissues is equivalent in congenic wild-type
and CD8α-/- mice, and priming of CD8+ T cells after CHIKV and RRV infection is delayed and dampened. The
mechanistic basis for how arthritogenic alphaviruses evade CD8+ T cell immunity is unknown. scRNAseq
analysis of CD8+ T cells in the draining lymph node of RRV-infected mice revealed reduced maturation and
proliferation in contrast to CD8+ T cells from LCMV-infected mice, which show a rapid conversion to effector T
cells. The impaired CD8+ T cell priming was reversed by loss of type I IFN signaling in DCs, which increased
viral infection and antigen in DCs; this result suggests that type I IFN paradoxically impairs CD8+ T cell priming
by limiting alphavirus infection of key antigen (Ag)-presenting cells (APCs). Separately, we found that viral Ag
presentation by CHIKV-infected or nsP2-transfected joint tissue fibroblasts was inefficient. Primary ankle
fibroblasts infected ex vivo failed to activate Ag-specific CD8+ T cells, and mutations in the CHIKV nsP2 protein
restored Ag presentation and CD8+ T cell activation. Finally, using intravital microscopy (IVM), we observed that
viral epitope-specific CD8+ T cells do not durably engage or kill RRV-infected cells. Our primary goal is to define
mechanisms by which arthritogenic alphaviruses evade CD8+ T cell-mediated clearance. In Aim 1, we
hypothesize that type I IFN restricts infection of myeloid cells which limits direct antigen presentation and the
timely priming of anti-alphavirus CD8+ T cells. We will determine the phenotype and infection status of APCs that
intrinsically can or cannot respond to type I IFN during alphavirus infection versus immunization. In addition, we
will determine how type I IFN signaling directly affects CD8+ T cell responses during alphavirus infection and test
if improved priming enhances clearance of alphavirus infection. In Aim 2, we hypothesize that alphavirus-
infected cells in joint tissue are inefficiently targeted by CD8+ T cells because the viral nsP2 protein disrupts
MHC-I Ag presentation. We will determine mechanisms by which CHIKV infection and nsP2 protein impair MHC-I
Ag presentation and define the extent to which this is a generalizable alphavirus immune evasion mechanism.
In Aim 3, we hypothesize that virus-infected cells in joint-associated tissues are inefficiently targeted by CD8+ T
cells because the priming environment generates CD8+ T cells that poorly engage virus-infected cells. We will
define how the intrinsic absence of type I IFN signaling in APCs regulates the differentiation and maturation of
CD8+ T cells during alphavirus infection and immunization. We also will use IVM to determine the impact of APC-
and CD8+ T cell-intrinsic type I IFN signaling on viral antigen-specific CD8+ T cell migration and homing. We will
define the frequency, duration, and outcome of interactions between CD8+ T cells and virus-infected cells.

Public health relevance
PROJECT NARRATIVE The mechanisms by which arthritogenic alphaviruses evade CD8+ T cells to avoid clearance from joint- associated tissues are poorly understood. This project will define mechanistically the virus and host pathways that promote evasion of CD8+ T cell responses by this important group of human viruses. The knowledge gained from these studies will enhance our understanding of the mechanisms by which viruses in general subvert CD8+ T cell immunity, which could aid in the development of immunomodulatory therapies or vaccines against arthritogenic alphaviruses, and possibly other viral or non-viral diseases in which evasion of CD8+ T cell immunity is a contributing factor.